PROPERTIES OF THE PRINCIPAL METABOLITES OF CYCLOPENTENYL CYTOSINE

The properties of the principal metabolites of the oncolytic nucleoside cyclopentenylcytosine (CPEC, NSC 375,575) are being examined. In the year past, the potency of CPEC-5'-triphosphate as an inhibitor of CTP synthetase has been confirmed and the Ki established as being approximately 1 X 10(-6)M using authentic chemically synthesized nucleotide as standard. Suggestive evidence has also been obtained that CPEC-MP is subject to deamination, presumably by deoxycytidylate deaminase inasmuch as this process is nearly totally inhibited by 2'-deoxytetrahydrouridine. Evidence that CPEC-5'-diphosphate is subject to reduction, at the level of ribonucleoside-5'-diphosphate reductase has also been obtained; if confirmed, this lead would provide a route for the intracellular generation of 2'-deoxy-CPEC-5'-monophosphate. Two diester anabolites of CPEC, presumed to be CPEC-5'-diphosphocholine and diphosphoethanolamine are being synthesized as chromatographic standards and as potential substrates/inhibitors of the appropriate cytidylyl transferases and lecithin synthesizing enzymes.